Molecular Mechanisms of Cellular Signaling by the Proton Pumping Vacuolar ATPase

PROJECT SUMMARY
Altered pH, metabolic homeostasis and autophagy are hallmarks of cancer, neurodegenerative
and infectious diseases. These fundamental processes are linked by a ubiquitous and essential
ATP-dependent proton pump called the vacuolar ATPase (V-ATPase). The V-ATPase is a large,
multisubunit, membrane-integral molecular machine whose canonical function is to acidify
intracellular organelles in all eukaryotic cells according to their functional requirements. More
recently, the V-ATPase has emerged in crucial non-canonical signaling roles including, but not
limited to metabolic homeostasis and vesicular trafficking. This research program aims to discover
the molecular mechanisms that drive V-ATPase’s ability to both acidify organelles and interact
with cellular factors to mediate signaling pathways. The current hypothesis is that the ability of V-
ATPase to multitask in these interdependent functions involves changes in V-ATPase subunit
composition and conformations that are linked to the enzyme’s reaction cycle. To address these
questions, (1) The complete reaction cycle of the V-ATPase will be delineated using cryo-electron
microscopy (cryo-EM) coupled with in vitro biochemical assays (e.g., ATPase and proton pumping
activity assays) and established yeast phenotypes for V-ATPase activity. (2) On early endosomes,
the V-ATPase acts as a pH-sensor to recruit a GTPase (Arf-6) and its GEF (Cytohesin-2) for
vesicular trafficking of substances to the lysosome. The molecular mechanism of this process will
be dissected using protein-protein interaction assays, cryo-EM, and endocytosis/trafficking of
albumin in kidney proximal tubule cells. (3) On lysosomes, the V-ATPase mediates metabolic
signaling by forming distinct supercomplexes with members of the mechanistic target of
rapamycin complex 1 (mTORC1) or AMP-dependent kinase (AMPK) pathways. It is hypothesized
that the V-ATPase, bound to a GEF called Ragulator acts as a common molecular switch to
promote either mTORC1 or AMPK signaling. The mechanism of V-ATPase-mediated metabolic
signaling will be elucidated using protein-protein interaction studies, in vitro reconstitutions, affinity
purification mass spectrometry, cryo-EM, and in-cell phosphorylation assays for mTORC1/AMPK
activity. The feasibility of this work is supported by the candidate’s expertise in the field as well as
robust preliminary experiments showing cryo-EM of V-ATPase (pertinent to goals 1, 2 and 3) and
interaction of V-ATPase with Cytohesin-2 (goal 2) and Ragulator (goal 3). Collaborations with
leaders in molecular dynamics and mass spectrometry further support these studies. Overall, this
research program will not only improve our understanding of V-ATPase mechanics but also reveal
key details of cellular pathways implicated in disease conditions.

Public health relevance
PROJECT NARRATIVE In all eukaryotic cells, intracellular organelles are acidified by an essential enzyme called the vacuolar ATPase (V-ATPase), a process required for fundamental cellular functions. In recent years, besides acidification, the V-ATPase has emerged as a key component in cellular signaling pathways that are implicated in cancer, neurodegenerative and infectious diseases. This proposal will investigate the molecular mechanism of cellular signaling by the V-ATPase, and its interplay with the canonical acidification mechanism of the enzyme.